Immunopathology Core

Project Summary - Immunopathology Core
A central unifying hypothesis of this research program is that MCC – both viral and UV-damage associated - is
a highly immunogenic tumor and, consequently, amenable to immune-oncologic intervention. This hypothesis
is supported by the presence of virus-specific T cells and antibodies in many of the patients as well as an
approximate 50% objective response rate (ORR) in metastatic MCC patients treated with monotherapy anti-
PD-1 or anti-PD-L1 monoclonal antibodies (mAbs). Unfortunately, many patients still fail to respond to PD-1
blockade. The overarching goal of the Immunopathology Core is to provide cutting-edge, slide-based, and
molecular technologies to interrogate the tumor microenvironment (TME), specifically to apply spatial
proteomics to understanding the critical cell-cell interactions occurring within the TME that either enable or
disable productive anti-tumor immune responses. We anticipate that these mechanistic insights will inform
future combination immune-oncology trials in MCC patients.

Public health relevance
Project Narrative - Immunopathology Core Although Merkel cell carcinoma (MCC) is a highly immunogenic tumor, many patients fail to respond to current immunotherapy with anti-PD1 agents. The Immunopathology Core will support all three projects by providing cutting-edge laboratory tests using tissue, DNA, and RNA to understand how tumor cells interact with the immune system. We hypothesize that through analyzing and understanding the cell-cell interactions (i.e., the social network) of the tissue microenvironment, we will learn what controls the generation of productive versus abortive anti-tumor immune responses and be able to apply that understanding to improve future therapy.